IGF::OT::IGF CORE INFRASTRUCTURE SUPPORT FOR SURVEILLANCE, EPIDEMIOLOGY, AND END RESULTS (SEER)

The aim of this Task Order modification is to support 2 initiatives: A pilot test to obtain medical claims data from Unlimited System, a medical claims aggregator (also referred to as a clearinghouse). Medical claims aggregators receive, edits, and submit insurance claims from medical practices. Working through a medical claims aggregator will ensure that this pilot test is conducted in the most efficient and cost effective manner because the desired oncology practice will be able to be recruited directly through the aggregator and once recruited the aggregator will directly submit their claims data. Also, since oncology practices are required to by law to submit data on newly diagnosed cases of cancer it is hoped that the option of claims aggregator submitted data will prove appealing. The goal of this pilot is to evaluate the feasibility of utilizing medical claims data to obtain longitudinal treatment data. A pilot test of methods for recurrence identification utilizing data collected by the Louisiana SEER registry as part of a Center for Diseases Control (CDC) Comparative Effectiveness Research (CER) funded study. The overarching goal is to identify the best strategy to capture recurrence information in a more automated and routine way within the cancer registry settings.